stress reduction intervention in caregivers

Subjects are accrued to this protocol once they have been identified and are serving as a primary caregiver for an individual planning to undergo an allogeneic HSCT at the Clinical Center, NIH. The patient and caregiver(s) are approached for participation before the patient starts their transplant conditioning. A sample of at least 78 caregivers is needed to adequately evaluate the effectiveness of the intervention for the planned primary analysis. Recruitment began in January 2015, and remains ongoing at this time. Currently there are 32 subjects enrolled, with n=24 completing all study procedures and five subjects have been removed from the study participation after enrollment.